Use of donor-derived cell-free DNA for risk stratification and post-treatment monitoring of lung transplant patients at risk for chronic lung allograft dysfunction

Project Summary
This is an application for the K22 NHLBI Career Transition Award for Dr. Michael Keller, M.D. Dr. Keller has shown great
promise as a young investigator, and has experience in conducting translational and observational research in lung
transplantation. However, he is now proposing to acquire advanced training in conducting longitudinal analysis and
comparative effectiveness research in lung transplant and requires additional training and mentorship to do so. His long-
term goal is to develop an independent research career as a physician-scientist conducting translational and
comparative effectiveness research focused on the development of interventions to prevent and treat chronic lung
allograft dysfunction (CLAD) in lung transplant patients. This award will provide Dr. Keller with the support and training
to accomplish this goal. He has assembled an experienced mentorship team including: Dr. Sean Agbor-Enoh (Primary
Mentor, Lung Transplantation), Dr. Hannah Valantine (Translational Research and Clinical Trials) and Dr. Dean Follmann
(Biostatistics). Through a combination of close mentorship, formal coursework and practical experience, Dr. Keller
proposes to accomplish the following training objectives: 1) acquire advanced skills in longitudinal analysis 2) acquire
skills in translational research, with a focus on clinical interventions and 3) acquire advanced skills in the design and
analysis of randomized controlled trials and prospective cohort studies.
Compared to other solid organ transplantation, lung-transplant patients have the lowest long-term survival, with a
median survival of 6.5 years. The leading cause of mortality after the first-year of lung transplant is CLAD, an irreversible
and progressive form of allograft failure that develops in about 50% of recipients by 5 years after transplantation. Given
that no reliable treatment options currently exist for CLAD, emphasis is placed on identifying and addressing recognized
risk factors, primarily acute lung allograft dysfunction (ALAD), in an effort to prevent disease onset. However, not all
patients who experience ALAD will progress to CLAD and identifying at-risk individuals is challenging with existing clinical
tools. Evidence suggests that donor-derived cell-free DNA, a molecular biomarker of lung allograft injury, may provide a
more sensitive and quantitative measure of the degree of lung allograft injury than traditional clinical tools, and better
define patients at risk for the development or progression of CLAD. The overall objective for this K22 application is to
identify emergent relationships between plasma dd-cfDNA levels of lung transplant patients at risk for CLAD and CLAD-
associated death. Dr. Keller proposes to accomplish this by pursuing three specific aims: 1) Identify key trends in plasma
dd-cfDNA levels prior to and at the time of diagnosis of ALAD that predict the risk of developing CLAD; 2) Define the
impact of cumulative allograft injury, as measured by dd-cfDNA, on CLAD severity and post-CLAD survival; and 3)
conduct a prospective cohort study to assess the correlation between post-ALAD treatment allograft injury kinetics,
assessed by dd-cfDNA, and risk of developing CLAD. The proposed research is innovative, in the applicant’s opinion,
because it represents a substantive departure from the status quo by evaluating allograft injury at the molecular level to
guide risk stratification, post-transplant monitoring and treatment response in lung transplant recipients. These
contributions will be significant because they are expected to provide strong scientific justification for the development
of future clinical studies aimed at the prevention and treatment of patients at heightened risk for CLAD and CLAD
progression, as well as trials evaluating the effectiveness of dd-cfDNA-based treatment goals in the treatment of ALAD.
Ultimately, such knowledge has the potential to offer new opportunities for the development of innovative monitoring
and treatment strategies in lung transplantation.
The central hypothesis is that elevated levels of dd-cfDNA prior to diagnosis, at the time of diagnosis and during
treatment of ALAD and CLAD increases the risk of developing CLAD and the progression of CLAD, respectively. The
rationale for the proposed research is that its successful completion is likely to establish a conceptual framework upon
which to base clinical recommendations for assessing CLAD risk and to guide effective treatment of ALAD towards
reducing the risk of CLAD in lung transplant patients, while at the same time, providing a pathway to establishing my
independence as a physician-scientist.

Public health relevance
Project Narrative The proposed research is relevant to public health because it focuses on developing a novel strategy to the approach of risk stratification and post-treatment monitoring of lung transplant patients based on the degree of molecular evidence of lung allograft injury. Once such strategies have been developed, there is potential for significant advancement in the routine monitoring and treatment of lung transplant patients resulting in decreased mortality and improved quality of life. The proposed research is relevant to the part of NHLBI’s mission to identify factors that account for individual differences in response to treatments and develop/optimize novel diagnostic and therapeutic strategies to prevent and treat lung disease.